Palliative Care for High-Grade Glioma

Brief Summary
WHO Grade III and IV gliomas (high-grade glioma or HGG) are aggressive, malignant primary brain tumors
that are devastating for older adult patients and caregivers due to high symptom burden, early physical and
cognitive decline, caregiver support needs, and existential distress stemming from life expectancy on the order
of months. Palliative care, defined by the National Quality Forum as “patient and family-centered care that
optimizes quality of life by anticipating, preventing, and alleviating suffering across the continuum of a patient's
illness”, is well-suited to meet the complex needs of these patients. Multiple oncological societies recommend
that palliative care be integrated early (within 3 months of diagnosis) into the treatment plan of all cancer
patients. Older adults have particularly high palliative care needs, in part due to shorter prognosis and
decreased tolerance for standard cancer-directed therapy. Generally, palliative care needs may be addressed
through a combination of primary palliative care (delivered by any front-line provider, including neuro-
oncologists) and/or specialty palliative care (delivered by a provider or multidisciplinary team with advanced
palliative care training and certification). The current literature suggests that patients with HGG do not have all
their palliative care needs met through primary palliative care from neuro-oncologists, yet they also are not
referred to specialty palliative care until they are actively dying. There is no established model for ensuring
their palliative care needs are met throughout the disease course. In this proposal, I present a conceptual
model of the barriers to comprehensive, timely palliative care for patients with HGG. My career goal is to
improve the delivery of palliative care for older adults with HGG. In this proposal I will: 1) use qualitative
methods to assess the range of knowledge, experience, and strength of preferences of older adults with HGG,
their caregivers, neuro-oncologists, and palliative medicine specialists regarding the domains of palliative care
and the optimal balance of primary and specialty palliative care for each domain; 2) use an existing cohort of
patients with HGG from a large health delivery system to measure the extent to which services or care
processes in each palliative care domain are delivered, and to analyze the associations between palliative care
delivery and overall HGG health care utilization. These two projects will be combined with my career
development plan, for which I have identified a team of expert mentors and advisors and am proposing
coursework relating to qualitative research methods and implementation science, as well as clinical rotations
and didactic learning about core concepts in geriatrics and aging research. This will set me on a path to obtain
a future career development award, which is the first step on my path to becoming an independent investigator
whose work improves the care of older adults with HGG.

Public health relevance
Project Narrative High-grade gliomas (HGG) are the most common primary malignant brain tumors, are more common in adults over age 65 years, and are characterized by debilitating neurologic symptoms and poor prognosis, with death occurring on the order of months. The negative effects of HGG on quality of life may be ameliorated through delivery of palliative care (which includes discussion of goals of care, symptom management, and addressing psychological, social, and spiritual needs, as well as end-of-life care when appropriate), particularly for older adults, who experience greater morbidity than younger patients with HGG. The research objectives of the current study are to elucidate barriers and facilitators to increased and earlier palliative care services for this vulnerable population, and assess current practice in addressing the domains of palliative care services for older adults with HGG, to inform the design of a future randomized controlled trial of a palliative care delivery model for people with HGG and their caregivers.